Modeling transcriptional and post-transcriptional systems for regulating non-genetic heterogeneity in mammalian cells

PROJECT SUMMARY
Recent advances of experimental techniques allow quantitative and systems‐wide measurements of non‐
genetic heterogeneity of mammalian cells, which serves as a crucial factor for stem cell dynamics and
differentiation potentials, as well as drug resistance of cancer cells. However, it remains challenging to
understand many puzzling observations regarding this type of heterogeneity in terms of underlying gene
regulatory networks. For example, progenitor cells restore their heterogeneity on timescales of days from
subpopulation with extreme gene expression patterns, and these cells switch from plasticity‐enabling
dynamics to robust commitment and pattern formation during differentiation; epithelial cells can be
distributed in a stable continuum in the epithelial‐mesenchymal spectrum upon receiving signals in
tumors. Existing theories provide very limited insights into these important dynamics and patterns. We
propose to combine mathematical modeling, new methods of analyzing gene regulatory networks and
gene expression data, and experiments in a motor neuron differentiation system, and systems involving
epithelial‐mesenchymal transition to study transcriptional and post‐transcriptional mechanisms
underlying non‐genetic heterogeneity in mammalian cells.
We propose to test a novel theoretical framework of a diverging oscillator for controlling progenitor cell
dynamics with both computational methods and experimental systems. We will rigorously formulate and
test a new hypothesis of an oscillator‐to‐switch transition for motor neuron differentiation in the
developing spinal cord. Stemming from our recent results on surprising post‐transcriptional mechanisms
for multistability and oscillation, we will use novel algebraic approaches to establish the relationship
between the number of microRNA bindings sites and biologically plausible cell states. We will test the
roles of microRNA binding in epithelial cell plasticity experimentally. We will examine the roles of
epithelial plasticity and microRNAs in dynamics of lung cancer cells. The success of the proposed study
will provide a new theoretical basis and new methods for interpreting and understanding dynamical gene
expression data on non‐genetic heterogeneity in mammalian cells. The theories and methods can used as
a foundation to develop therapeutics for diseases related to development, tissue degeneration and cancer.

Public health relevance
PROJECT NARRATIVE Dynamics of mammalian progenitor cells and epithelial cells play crucial roles in normal development, physiology and cancer progression. The proposal aims to study the molecular and cellular mechanisms for the plasticity and lineage commitment of these cells in terms of underlying gene circuits, which will lead to better understanding of developmental diseases, degenerative diseases and cancers.